Investigating RNA polymerase III driven mechanisms in regulating HIV latency

ABSTRACT
Resting CD4+ T cells harbor majority of latent Human Immunodeficiency Virus (HIV) during
infection. Elimination of this reservoir is an extremely challenging task because of involvement of
multiple mechanisms in regulating HIV latency. Therefore, perhaps, none of the currently
promising latency reversing agents (LRAs) were able to reduce the size of the latent proviral
reservoir in patients. Hence, there is a dire need to find novel mechanisms and therapeutic targets
that can be targeted to purge the heterogenous latent reservoir. RNA Polymerase III (RNA Pol III)
appears to be a master regulator with unexplored potential of regulating latency via mediating
distinct mechanisms, such as i) regulating the expression from neighboring RNA Pol II gene
promoters and ii) transcription of novel noncoding RNAs with potential to regulate expression of
cellular/viral genes. Our preliminary studies suggest the enrichment of Pol III transcribed
noncoding RNAs in latent cells, namely 7SK, 21A and BC200 that are interspersed among Alu
repeats. This is highly relevant to HIV latency because the HIV genome is found to preferentially
integrate near Alu repeats. Consequently, use of an RNA Pol III inhibitor, ML60218, resulted in
an unprecedented reactivation (up to 90%) of latent cell lines J89GFP and THP89GFP, in a dose-
dependent manner (25 μM-50 μM). Further, we observed a high degree of cell death specifically
in HIV infected cells due to viral cytopathic effects, whereas uninfected cells maintained survival
even at a very high concentration of RNA Pol III inhibitor (100 μM). These exciting findings and
corroborating reports will be leveraged to test the hypothesis that RNA Pol III plays a crucial
role in the establishment of HIV latency and targeting novel intermediate effectors of RNA
Pol III driven mechanisms may enhance the efficacy of cure strategies. This study is divided
into two specific aims that will be focused on investigating RNA Pol III driven direct (by genomic
occupancy) and indirect (by ncRNAs) mechanisms that may regulate HIV latency. In Aim 1, effect
of RNA Pol III inhibition/knockdown will be tested in ex vivo cultured primary CD4+ T cell model.
Further in Aim 1.2 we will investigate if physical presence of RNA Pol III in proximity can modify
chromatin landscape at HIV 5´ LTR. In Aim 2, we will identify RNA Pol III transcribed noncoding
RNAs involved in latency by employing RNA-seq in combination with RNA Pol III ChIP-Seq.
Finally, gene knockdown studies will be performed for select noncoding RNAs alone or in
combination to investigate their role in promoting repressed chromatin state at HIV 5´ LTR. Our
study is highly innovative as we aim to identify novel epigenetic modulators that can be
synchronously targeted to overcome challenges associated with shock and kill strategy of HIV
cure. Successful completion of this study will provide critical mechanistic information which may
address the heterogeneity among latent reservoirs.

Public health relevance
NARRATIVE We intend to investigate the role of host RNA polymerase III driven mechanisms in establishing persistent HIV-infection in certain cell types that typically serve as viral reservoirs in treated patients. This is very logical because this molecule may control the expression of HIV-1 by direct mechanisms via physically hindering the transcription from HIV promoter or indirectly by synthesizing an important subset of noncoding RNAs that may repress promoter. As such, an outcome of our study is expected to be instrumental in designing comprehensive novel strategies to eliminate the viral reservoirs from HIV infected individuals.